Hepatic Clearance Chip for Pharmacokinetics

Drug metabolism and pharmacokinetic testing (DMPK) is crucial for understanding the clearance mechanisms,
clearance rate, and any potential drug-drug interactions of small molecule drugs during lead optimization prior
to initiating in-human clinical trials. DMPK testing is currently performed using animal models, usually rats.
However, these studies are problematic for several reasons: 1) Animal-based DMPK studies are expensive and
create a large financial burden during lead optimization; the top 20 pharmaceutical companies spend >$1.2
billion each year on PK testing, with over 1 million animals used by industry per year; 2) They are time-consuming
and delay the collection of important data. For example, the synthesis of each compound needs to be scaled up
from µg to mg quantities before rat studies can be initiated. 3) While higher animal species, such as dogs, pigs,
and non-human primates, have greater human relevance, they are more expensive than rodent studies and
require synthesis of even greater quantities of active pharmaceutical ingredient (API); and 4) The ability of animal
models to predict human outcomes is controversial. Although recent attempts have been made to identify in vitro
approaches, these are all limited in terms of reliability, long-term analysis ability, reproducibility, poor reflection
of in vivo hepatic transport, clearance, and metabolism. Thus, the pharmaceutical industry needs better
approaches for DMPK testing that are more predictive, cheaper, and faster than currently available in vitro and
in vivo methods. Successful development of such a system will improve safety and help reduce the ~90% of
drug candidates that currently fail in clinical trials.
In solution to this unmet need, we propose an integrated (in vitro and in silico) hepatic clearance platform that
merges a human liver tissue chip and translational software. This technology can predict human hepatic
clearance parameters accurately in 2 weeks without the need of API scale-up. Javelin is the only organization
pursuing this technology for drug metabolism & disposition, which requires design features that are unique to
DMPK studies and that cannot be met using microphysiological systems designed for toxicology and
pharmacology applications. The purpose of this Direct to Phase II SBIR proposal is improve our technology
ready for launch by optimizing the chip design to enhance usability, evaluate drug clearance mechanisms, and
assess the clinical translation of our technology. This will be achieved through the following Aims: 1) System
design optimization; 2) Evaluation and characterization of known drug clearance mechanisms on the Javelin
hepatic clearance chip; and 3) Assessment of in vitro to in vivo translation to predict clinical outcomes. Successful
application of our tissue chip perfusion system will reduce the need for other preclinical models to estimate drug
PK outcomes, thereby reducing the risk and cost associated with drug development. Indeed, our early evidence
indicates that we can predict clinical outcomes 15% more accurately and in a manner 10-times cheaper and 10-
times faster than rat studies.

Public health relevance
During drug development, it is crucial to understand the clearance mechanisms, clearance rate, and any potential drug-drug interactions of small molecule drugs to ensure safety; however, the rat models currently used for this purpose are sub-optimal in terms of time, cost, and applicability to humans. Our solution to this unmet need is an integrated platform that merges a human liver tissue chip and translational software that will reduce the cost and risk associated with drug development. Successful completion of this proposal by optimizing the chip design to enhance usability, evaluating and validating different drug clearance mechanisms, and comparing Javelin’s clinical predictions to known human clearance profiles, will advance the commercial readiness and accelerate commercial adoption of Javelin’s Hepatic Clearance platform, delivering improved R&D productivity to industry and better drugs to patients.